black cohosh in Laboratory Animals for the National Toxicology Program (NTP)

The goal of this project is to evaluate the chronic toxicity and carcinogenicity of black cohosh in rats and mice exposed by gavage. widespread use by women as a dietary supplement to alleviate abnormal or painful menstruation (amenorrhea, dysmenorrhea and other conditions) and perimenopausal symptoms. 2-Year chronic gavage toxicity and carcinogenicity studies of black cohosh are in the in life phase. Keywords: toxicity, carcinogenicity, gavage, black cohosh